Redefining kidney developmental origins

Abstract
Investigations of embryonic development are critical for understanding congenital anomalies that arise
from altered development. Additionally, the derivation of tissues in vitro from pluripotent cells relies on directed
differentiations along developmental pathways. However, this has proven challenging for organs such as the
mammalian kidney which proceeds through three different phases of development along the anterior to posterior
axis before the third phase induces development of the final, metanephric kidney. Questions remain about
whether cellular programs of the metanephric kidney are actually induced in vitro or whether they represent
earlier phases of development. The intermediate mesoderm, which is thought to derive independently of the
adjacent paraxial and lateral plate mesoderm from the primitive streak, generates the kidney tissues, gonads,
and adrenals. The metanephric kidney is induced to form caudally at the hindlimb level. However, despite over
a century of research into the intermediate mesoderm and metanephric kidney development, the origins remain
clouded by studies focusing on anterior intermediate mesoderm, conflicting results, and building evidence that
may suggest alternate mesodermal origins. Our own imaging of early embryos as well as a thorough
consideration of previous findings has led us to hypothesize that the intermediate mesoderm which gives rise to
the metanephric kidney is derived from paraxial mesoderm. Therefore, it is imperative that we reexamine the
intermediate mesoderm and kidney origins considering these findings. Advances in tools and methodology
available will enable us to interrogate intermediate mesoderm and metanephric kidney development and shed
new light onto the cellular origins. In Aim 1 we will perform novel lineage traces of paraxial mesoderm and utilize
whole embryo light-sheet and live imaging to examine the paraxial, intermediate, and kidney cell populations at
critical developmental timepoints to ascertain their identity and origins. In Aim 2, we will utilize directed
differentiations from induced pluripotent stem cells (iPSCs) to test whether in vitro derived paraxial mesoderm is
competent to generate intermediate mesoderm and kidney tissue. Together, we predict that these novel and
innovative studies will redefine and refine the cellular origins of intermediate mesoderm and its derivatives. These
findings will contribute essential foundational knowledge to the field of developmental biology and aid the
development of effective tissue replacement and regenerative strategies, as well as further our understanding of
developmental anomalies which significantly affect human health.

Public health relevance
Project Narrative Deciphering the developmental programs which give rise to tissues and organs is critical for the generation of new technologies and therapeutics, such as regenerative therapies. Despite over a century of discovery, our understanding of embryonic intermediate mesoderm formation, which gives rise to the kidneys, gonads, and adrenals, remains unclear. Our studies have the potential to redefine the developmental origins of the intermediate mesoderm and kidney, enabling the refinement of differentiation protocols and changing our foundational knowledge of developmental programming.